IMPROVING COVID-19 VACCINATION UPTAKE IN HIV POSITIVE PREGNANT WOMEN IN NIGERIA

A. Project Summary/Abstract
With the current global devastation and loss of lives, livelihood, and share suffering as a result of
the COVID-19 pandemic, especially with the weak health care systems and limited resources in
Africa, there is need to conduct research that will provide valuable information on treatment and
prevention options and to understand the peculiarities of different populations as they respond.
The effective COVID-19 vaccines have been largely instrumental to success in fighting the
pandemic in the last 18 months. While most countries in the developed world have vaccinated
over 70% of their population, only 21 African countries have fully vaccinated between 10% and
19% of their populations. Nigeria has only vaccinated 7.2% of its adult population and boosted
only 0.4% and there is currently no data of vaccination in pregnant women or HIV infected
persons. Even with the improved access of vaccines to Africa, vaccine hesitancy continues to limit
the ability to improve vaccine coverage in these countries. Our ongoing NIH funded BEAMING
grant (5U01HD094658) situated at a tertiary hospital where we have conducted research for
over 20 years and including two prospective natural history birth cohort studies in HIV is
uniquely placed to rapidly provide information for the first time from this part of the world
that is this vulnerable population. This supplemental submission builds on the BEAMING
experience and infrastructure to address research questions of great public health importance
on social and culture norms that could explain vaccine hesitancy in this vulnerable population.
We plan to use the information to develop culturally and socially acceptable educational
materials and sessions that target drivers of vaccine hesitancy in HIV pregnant women and their
matched uninfected pregnant controls in Nigeria, with the objective of re-shaping policies and
strategies towards improved COVID-19 vaccines uptake in preparation for other waves of SARS
COV-2 or future pandemics through three specific aims. Aim 1 will document social and cultural
reasons for COVID-19 vaccine hesitancy among pregnant women in Nigeria and whether HIV
infection creates an additional layer of burden. Aim 2 will develop strategies and educational
materials to improve COVID-19 vaccine hesitancy and coverage in this population based on
responses obtained from Aim 1. Aim 3 will document for the presence of anti- SARS-CoV-2
antibodies in infected pregnant women with or without HIV-1 infection; and if possible, the
presence of anti- SARS-CoV-2 passively transferred antibodies in their infants.

Public health relevance
Project Narrative Our study will carry out discussions with HIV-infected and uninfected pregnant women, to find out their worries about taking the COVID-19 vaccines. Based on their responses, we will design educative materials that address their worries to educate them, and to provide information to policy makers so that they can include this group when they design national policies and guidelines. We will also test pregnant women that are vaccinated to make sure that they also make soldiers to fight the COVID-19 when they are vaccinated.